Temporal and Spatial Control of Oligodendrocyte Fate Specification

PROJECT SUMMARY
The long-term goal of this project is to understand how oligodendrocytes, the myelinating glia cell type of the
vertebrate central nervous system, are formed during development. In the ventral spinal cord and dorsal
forebrain, neural progenitors first produce neurons followed by oligodendrocyte precursor cells (OPCs), which
migrate and divide to populate the neural tube. Subsequently, many OPCs stop dividing and differentiate as
myelinating oligodendrocytes. Whereas we know a considerable amount about the mechanisms that promote
oligodendrocyte differentiation and myelination, we know very little about mechanisms that regulate the very
earliest steps in specifying progenitors for oligodendrocyte fate. Based on our in vivo, live imaging-based fate
mapping studies, we discovered that different spinal cord and forebrain progenitor cells produce neurons and
OPCs. We have now used single cell RNA-seq analyses to identify a transcriptional state of these pre-OPC
progenitors, and have identified candidate cell-intrinsic programs and cell-extrinsic pathways that are conserved
between nervous system regions and across vertebrate species. Using zebrafish and mice as model systems,
this project will identify the molecular mechanisms that guide formation of OPCs from neural progenitors. Specific
Aim 1 will test a hypothesis that the pioneer transcription factor Ascl1 establishes the epigenetic and
transcriptional state of pre-OPCs. Aim 2 will investigate the mechanisms by which Notch signaling selects a
subset of neural progenitors for a pre-OPC fate. Specific Aim 3 will test a hypothesis that the transcription factor
Gsx2 helps specify a pre-OPC state and/or regulates a pre-OPC to OPC transition. The results of this project
have the potential for important new insights into developmental myelination, the causes of myelin disease and
potential strategies to restore myelin following disease and injury.

Public health relevance
Proper formation of distinct types of neurons and glial cells in the central nervous system is essential for motor and intellectual function. The long-term goal of this project is to understand how oligodendrocyte lineage cells, which includes cells that wrap axons with insulating myelin, are produced by neural progenitors. Completion of the project aims will substantially extend our understanding of the molecular mechanisms that control formation of glial cells for myelination.